Kentucky's Flexible Funding Model - Infrastructure Development and Maintenance for State Manufactured Food Regulatory Program.

KENTUCKY CABINET FOR HEALTH AND FAMILY SERVICES, DEPARTMENT FOR PUBLIC HEALTH
RFA-FD-18-001
FLEXIBLE FUNDING MODEL – INFRASTRUCTURE DEVELOPMENT AND MAINTENANCE FOR STATE FOOD
REGULATORY PROGRAMS (U 18)
SUMMARY
The goal of the Kentucky Food Safety Branch is to continue to be an active participant in the nationally
integrated food protection system. Chief in accomplishing this goal, as well as the goal of continuing
program improvement, is participation in the MFRPS. The five year Cooperative Funding Agreement has
allowed our state food protection program to address many of the identified gaps and obstacles, and
has allowed our agency to implement a fully-functional MFRPS program in Kentucky. This in turn has
allowed our state to achieve and sustain significant to full conformance with the MFRPS.
In summary, the intended outcome of the Cooperative Agreement Funding Application is to further
advance efforts for a nationally integrated food safety system by utilizing available federal (FDA) funding
assistance, thus allowing Kentucky's State Manufactured Food Regulatory Program to continually
improve and maintain full conformance with the Manufactured Food Regulatory Program Standards
(MFRPS). The MFRPS program funding will be utilized to ensure that Kentucky's manufactured food
regulatory programs develop and maintain best practices for a high-quality regulatory program. Full
participation in the MFRPS program will assist our federal (FDA) partners in establishing a uniform basis
for measuring and improving the performance of manufactured food regulatory programs in the United
States.

Public health relevance
MFRPS Outcome The intended outcome of the Flexible Funding Model – Infrastructure Development and Maintenance for the Manufactured Food Regulatory Programs Standards (MFRPS) is to further advance efforts for a nationally integrated food safety system that by utilizing available federal (FDA) assistance to allow Kentucky to further develop and maintain best practices for a high‐quality regulatory program. Conformance and maintenance with the program standards will provide a uniform basis for measuring and improving the performance of Kentucky's manufactured food regulatory program, assist Kentucky in better direct regulatory activities at reducing foodborne illness hazards in plants that manufacture, process, pack or hold foods.